Behavioral biomarkers for prediction of mortality and seizures in epilepsy

There are 65 million people worldwide with epilepsy and 150,000 new cases of epilepsy are diagnosed in
the US annually. Treatment options for epilepsy remain inadequate, with many children and adults with
epilepsy suffering from treatment-resistant seizures and are at increased risk for mortality. A major, long-
standing, currently unmet challenge for preclinical epilepsy research is to develop and test novel biomarkers
that could identify individual animals that are the most likely to develop epilepsy after brain trauma and suffer
mortality, as well as monitor, predict and control seizures in chronically epileptic animals in a non-invasive
manner. Recently, in a synergistic, collaborative effort, the Soltesz and Datta labs showed that artificial
intelligence (AI)-assisted 3D video analysis of spontaneous mouse behaviors can automatically phenotype and
sort non-epileptic versus epileptic mice in a purely data-driven manner without observer bias, revealing hidden
behavioral phenotypes for both acquired and genetic epilepsies, stages of epileptogenesis, and drug
treatments. This methodology, called Motion Sequencing (MoSeq), breaks down complex animal behaviors
into stereotyped modules that follow each other with characteristic transition probabilities at sub-second
timescales. Here we propose to use mouse models of temporal lobe epilepsy and Dravet Syndrome in
combination with various cutting-edge MoSeq-based approaches to identify novel, non-invasive, predictive
behavioral biomarkers for chronic seizures and mortality purely from video recordings of spontaneously
behaving animals. In addition, we propose to examine the neuronal dynamics underlying the altered expression
patterns of behavioral modules in chronic epilepsy in vivo. Finally, we propose to adapt MoSeq for prolonged
24/7 epilepsy monitoring of mice under realistic environmental conditions and social settings, and test non-
invasive focused ultrasound technology for innovative closed-loop interventions triggered by the appearance
of predictive behavioral biomarkers to control seizures. We anticipate that the results from this research will
have a potentially transformative effect on the field by demonstrating the feasibility and power of automated,
objective, user-independent, predictive behavioral biomarkers for the epilepsies.

Public health relevance
Children and adults with epilepsy often experience uncontrolled seizures and are at increased risk for mortality. The project will apply recently developed breakthrough technologies involving artificial intelligence (AI)- assisted analysis of 3-dimensional video data of mouse behavior to identify novel ways to predict epilepsy development and heightened risk for mortality, as well as monitor, predict and control seizures in already epileptic brains in a non-invasive manner. If successful, this innovative approach will address long-standing, fundamental challenges in preclinical epilepsy research and accelerate the development of novel therapies.